Diversity Supplement: Placenta-specific miR-519c-mediated induction of immune tolerance in human placenta - Revision - 1

SUM M ARY/ABSTRACT
Pregnancy represents a unique challenge for the maternal-fetal immune interface, requiring the balance between
immunosuppression, essential for maintaining semi-allogeneic fetus and pro-inflammatory host defense to
protect the mother and fetus from invading organisms. Adaptation to repeated inflammatory stimuli may be
critical in preventing the rejection of the fetus by the exaggerated maternal inflammatory responses to
mild/moderate infections that are common during human pregnancy. This adaptation suppresses an overly
aggressive inflammatory response to repeated infections that can be detrimental to the tissues rather than
protective. Our data point to the involvement of a human and placenta-specific miRNA called miRNA-519c-3p
(miR-519c) in the development of placental immune tolerance. Our overriding hypothesis of the parent RO1
grant (titled: Placenta-specific miR-519c-mediated induction of immune tolerance in human placenta, 5T R01-
HD098258-04) is that repeated exposure of the placenta to pathogens will induce a tolerant phenotypemediated
by the placenta-specific miR-519c to guard the maternal-fetal interface from the exaggerated inflammation
associated with pathologic pregnancies.
• Aim 1: Investigate the role of placenta-specific miR-519c in mediating immune adaptation in the
human placenta after repeated bacterial toxin challenges.
• Aim 2: Investigate the molecular mechanisms of placental miR-519c mediatingimmune tolerance.
This supplement proposal seeks support for Ms. Rahanna Khan, a second-year Ph.D. student with long-term
goals to be an independent researcher in environmental health. Ms. Khan has focused her research interest on
studying environmental impacts on reproductive and developmental health and strives to specialize in
translational research within this field. Aim 1 of the parent RO1 hypothesizes that miR-519c deficiency will lead
to placental immune tolerance failure resulting in infection-induced preterm birth. However, it is unclear why
some women are deficient in placental miR-519c and, therefore,more susceptible to pretermbirth. The proposed
supplement will examine the role of the environmental toxin polybrominated diphenyl ether 47 (PBDE-47) in
decreased placental immune tolerancethrough deficient miR-519c signaling. PBDE-47 is a persistent,ubiquitous
flame retardant that is correlated with the incidence of preterm birth and is detectable in the majority of American
women's serum. We hypothesize that PBDE-47-treated placental cells will alter placental immune tolerance and
reduce the amount of miR-519c produced in placental extracellular vesicles (EVs). The aims are as follows:
• Aim 1: Determine the effects of PBDE-47 exposure on placental immune adaptation
• Aim 2: Characterize the effects of PBDE-47 on placental EV-miR-519c production.
This study may elucidate a novel mechanism by which PBDE-47 exposure contributes to human preterm birth
through reduced miR-519c expression and provide an in vitro alternative model for future mechanistic studies.

Public health relevance
NARRATIVE This proposal addresses novel and cutting-edge concepts regarding the role of placenta-specific microRNAs in regulating exaggerated inflammation after repeated infections during pregnancy. This study may elucidate a novel mechanism by which the environmental toxin “PBDE-47” exposure can potentially contributes to human preterm birth through reduced placenta-specific microRNAs expression.